SLEEP STAGE AND COLONIC MOTOR ACTIVITY IN PATIENTS WITH IRRITABLE BOWEL SYNDROME

Investigations into the mechanism of symptoms in the irritable bowel syndrome (IBS) have revealed both sensory and motor abnormalities, suggesting altered gut neural control. Normal gut neural control exists at 3 levels (CNS, ANS, and ENS) yet the level of derangement in IBS remains controversial. This study will evaluate whether the sleep stage/colon activity relation is disturbed in IBS.